The Application of Generalized Linear Models to Calcium Imaging Data for Optimal High-Dimensional Receptive Field Estimation and Identification of Latent Network Dynamics

Abstract As new recording methods emerge in neuroscience, new statistical techniques are needed to properly relate neural activity to behavior, a given stimulus, or an internal process. Calcium imaging techniques are now widely used in the ﬁeld of neuroscience due to their ability to easily record many neurons simultaneously. However, many existing statistical techniques and are formulated for spiketime data. In particular, generalized linear mod- els (GLMs), are developed under the assumption that neural data is in the form of individual spike times. Here, in Aim 1, we propose a framework for extending GLMs to rapidly characterize high-dimensional neural recep- tive ﬁelds directly from calcium traces. We additionally extend the capabilities of these methods by introducing smoothing priors over receptive ﬁeld statistics and methods to learn the properties of individual calcium traces on a per-neuron basis that will allow for rapid and ﬂexible implementation. In Aim 2, we will use these algorithms on two existing datasets from Ilana Witten (Princeton) and Spencer Smith (UNC) to characterize neural response properties in a spatial reward task and a visual psychophysical task. We will formally quantify both spatial tuning in prefrontal neurons and receptive ﬁeld properties in a range of cortical visual areas in rodents. In Aim 3, we will extend our model to elucidate neural properties as functions of internal network dynamics. This will include identifying pairwise neural inﬂuences by including post-spike ﬁlters from simultaneously recorded neural units, and additionally learning a latent dynamic signal that may be shared across all neurons in a given cortical re- gion. Due to the many simultaneously recorded calcium traces in our dataset, we will be able to use to our GLM framework to offer insight into how neural networks process and communicate information to different cortical regions for a range of experimental tasks. Our formalized GLM framework will be efﬁcient, ﬂexible, and generalizable across experiments, brain regions, and even animals. We will make our models available for public use upon their publication such that the calcium imaging community can easily adopt them to help answer their own experimental questions.

Public health relevance
PROJECT NARRATIVE Our research is central to the mission of the BRAIN initiative as it constitutes a necessary extension of existing statistical tools to new calcium imaging recording techniques. The suite of models and analyses developed here demonstrate a ﬂexible, efﬁcient method for characterizing high-dimensional neural activity in experimental set- tings and understanding neural circuits. Describing the fundamental coding properties of these neural circuits marks a crucial ﬁrst step in understanding mammalian brain function and ﬁnding ways to treat and cure mental disease.